INTEGRATIVE MOLECULAR ANALYSIS CORE

INTEGRATIVE MOLECULAR ANALYSIS CORE – PROJECT SUMMARY
The Integrative Molecular Analysis Core (IMAC) at the University of New Mexico (UNM) plays a crucial role in
supporting research on metals in biology and medicine, providing specialized expertise and high-end
equipment beyond the capacity of individual labs. Throughout Phase I, the IMAC has been instrumental in
assisting mentored research project leaders (RPLs) and pilot project principal investigators in their pursuit of
independent funding, leading to impactful publications, collaborations, and R01 grants for early-stage
investigators. In response to growing user demands, the IMAC has secured over $4 million through research
instrumentation grants including an NIH S10, two CoBRE supplements, and an award from New Mexico's
Technology Enhancement Fund, enabling significant equipment acquisitions and facility upgrades. Now
established, the overarching goal for the IMAC in Phase II is to sustain and expand this innovative core by
focusing on three specific aims. First, the IMAC will empower Phase II RPLs with the technology, support, and
expertise to elevate their research on metals in biology and medicine. To this end, the IMAC will integrate
cutting-edge technologies, particularly in spatial imaging through mass spectrometry, which aligns with IMAC's
focus on metals and biomolecular analysis in cells and biological samples. This aim seeks to bolster the RPLs'
research quality, enhance reproducibility, and improve their competitiveness for NIH-R01 funding. Second, the
IMAC aims to support and expand the user base by providing expert service, training, collaboration, and
dissemination of new technologies. The goal is to build a critical mass of users across the UNM Health
Sciences Center, main campus, and other regional research institutions. Third, the IMAC will build a path to
long-term sustainability by enhancing core operations and fostering increased utilization at state and regional
levels. To accomplish this aim, the IMAC will expand outreach initiatives to include new state, regional, and
IDeA partners, in addition to renovating newly allocated space to accommodate additional users and
instruments. This approach is designed to increase core usage, leading to sustained operations beyond
CoBRE funding phases, and to extend the reach of the IMAC's advanced molecular analysis capabilities.
These combined efforts are expected to drive multidisciplinary research on metals in biology and medicine,
support RPLs in achieving research independence, increase collaborations within UNM and across other IDeA
states, and facilitate scientific innovation in addressing metal-mediated diseases, which impact millions of
people in New Mexico and globally.